Toward a Curative Treatment for HBV with cccDNA-Targeting Peptide Nucleic Acids

PROJECT SUMMARY
Hepatitis B virus (HBV) infection remains an incurable disease. Despite the availability of vaccines and
potent anti-viral drugs, nearly 300 million people worldwide are infected with HBV. The challenge with
curing HBV is the persistence of the virus’ genome in the form of a double-stranded covalently closed
circular DNA, or cccDNA, in the liver cells of patients. Unfortunately, the most modern nucleoside analogs
(NUC) drugs do not eliminate cccDNA and infection is never fully cleared. To ultimately achieve a cure for
HBV, a new class of drugs are needed that can specifically induce degradation or loss of the cccDNA.
This project will address the need for cccDNA targeting drugs by proposing to develop peptide nucleic
acids, or PNAs, as a therapeutic. PNAs are similar to small nucleic acid therapeutics that have already
been FDA approved, like Patisiran or Nusinersen. However, unlike other small nucleic acid drugs, PNAs
have the unique ability to directly bind to double-stranded DNA (dsDNA) and induce damage or
degradation. And unlike some biologics are being developed that can also bind and degrade dsDNA, like
CRISPR-Cas systems or TALENs, PNAs are extremely stable, exhibit low toxicity, are highly sequence
specific, and are deliverable without formulation of as nanoparticle formulations. PNAs can also build on
the successful development of FDA-aproved liver-targeted nucleic acid therapeutics like Patisiran.
This project will first establish sensitive cccDNA detection and characterization methods to track
changes in cccDNA during the course of experimental treatments with PNAs. It will design, synthesize
and test a small library of PNAs that can target and potentially induce the degradation of cccDNA. These
will include two PNA binding modes to the cccDNA and DNA-modifying chemical conjugates, including
DNA alkylation and phosphodiester bond cleavage. These PNAs will be characterized in vitro and in cell
culture models of HBV. The best PNA designs will then be tested in mouse models using two modes of
delivery, direct injection or lipid nanoparticle (LNP) formulation, and their acute toxicity, immunogenicity,
and tissue distribution characterized. Finally, the best PNAs will further characterized for their dosing,
duration of effect, and ability to eliminate cccDNA in two mouse models of HBV. Together, these results
will evaluate the potential of PNAs to serve as a drug candidate for clearing cccDNA from infected animal
models of HBV. If successful, one or more lead PNAs could be identified for immediate preclinical
development to cure HBV, either alone or combined with currently prescribed NUCs or other antivirals.

Public health relevance
Project Narrative Hepatitis B virus (HBV) infection is an incurable viral infection of the liver that causes hepatocarcinoma and cirrhosis. Even when treated with the best available drugs, HBV causes other long-term health problems for patients because of a persistent viral genome known as covalently closed circular DNA, or cccDNA. To eliminate cccDNA and cure HBV, this proposal creates a group of compounds known as peptide nucleic acids and tests their ability to target and degrade cccDNA in animal models of HBV.